Digital Peer Support for Opioid Use Disorders: Scaling Chat Support Groups to meet Community Needs

PROJECT SUMMARY
90% of Americans with SUD are not in treatment. When patients receive care, they do so
inconsistently. The average length of time an American spends in treatment before seeing a full
year of recovery is 9 years. Peer Support is proven to be effective at engaging patients who are
unwilling to engage with traditional treatment. Outcomes from current face to face peer models
have shown reductions in inpatient utilization and positive clinical outcomes such as improved
recovery capital. While there is some evidence that group models such as AA and NA are
effective for some patients, their support is siloed away from other clinical care and community
support. Our solution, Marigold Recovery Service (MRS) is a novel, machine learning enabled,
digital peer support program that is built on top of an anonymous text-based social network. It
fulfills the need for a robust, 24/7, secure platform to support patients at all stages of their
recovery. This phase I proposal will demonstrate the ability of our service to engage and retain
patients with Opioid Use Disorders and will also develop novel techniques to automatically
analyze patient messages for clinical and social determinants of health-related needs.

Public health relevance
PROJECT NARRATIVE The widespread and chronic nature of opioid use disorder (OUD) necessitates investment in highly scalable technology solutions. Our work has the potential to engage the hardest to reach patients, particularly those in highly stigmatized and geographically isolated populations, giving them 24/7 access to supportive recovery communities. While there are other peer models that incorporate virtual support, Marigold's model is powered by novel and evolving technology, uniquely adept at integrating with and building upon existing care plans, and specifically designed for Medicaid members disproportionately impacted by the opioid and COVID 19 epidemics.